Developmental Research Program

The objectives of the Developmental Research Program (DRP) are to continue to renew our innovative scientific endeavors within the DF/HCC Lung Cancer SPORE and to fund efforts that will complement and enhance the overall quality of the DF/HCC Lung Cancer SPORE. The Developmental Research Program will fund both established and junior investigators as we have in the past. We will set aside $50,000 per year for the Developmental Research Program Awards from SPORE funds. The DF/HCC SPORE has an extensive track record of using institutional funds to support our Developmental Research Program. This will be supplemented with an additional $250,000 per year in institutional support as we have in the past. Three to 5 individuals will be awarded each year for as much as two years of funding. The second year of funding will be dependent on making sufficient progress on review by the Developmental Research Program. The award will facilitate the research and development of independence of basic biological science, translational science, and applied science investigators within the DF/HCC Lung Cancer SPORE program. Thus, candidates will be fellows, postdoctoral fellows, and faculty within the different training programs across the Harvard campus. Success in this Developmental Research Program Will be defined as the development of innovative translational science that will generate cancer-relevant interventions in patients with lung cancer or populations at risk for lung cancer. This program will use the infrastructure created by the Administration, Evaluation and Planning Core to: 1. Solicit applications and/or identify novel research projects in the area of lung cancer 2. Evaluate these projects for financial and core support 3. Fund innovative developmental research projects 4. Monitor progress on projects for potential transition into full project status 5. Evaluate the program's success in achieving its goals as well as overall SPORE objectives